Integrative proteogenomics for elucidation of tumor-specific cell surface proteomes in ultra-rare cancers

Project Summary
Despite advances in treatment, sarcomas like rhabdoid tumors and desmoplastic small round cell tumors
(DSRCT) remain challenging, with frequent therapy resistance and fatal outcomes. The rarity of these cancers
(<1 case per 1,000,000 people per year for each type) and the limitations of current genomics and proteomics
methods underscore a critical need for innovative approaches to discover improved targets for therapy. Our
project aims to propel the study of ultra-rare cancers by integrating cutting-edge genomic and proteomic
technologies to uncover tumor-specific biological mechanisms and therapeutic targets, as envisioned by the
FDA Oncology Center of Excellence. Our overarching goal is to elucidate the fundamental biological processes
and molecular mechanisms driving cancer pathogenesis, specifically for rare cancers such as rhabdoid and
DSRCT tumors. By defining their tumor-specific proteomes, we seek to enable the discovery of specific
therapeutic targets to improve the survival rates of children and adults facing these refractory cancers.
Leveraging a unique MSK cohort of over 80,000 diverse patients with active disease, including those with
rhabdoid and DSRCT tumors, we propose a synthetic integration of long-read sequencing of bulk DNA, bulk
RNA and single cell RNA, and high-resolution multidimensional mass spectrometry proteomics. This approach
will enable us to construct comprehensive maps of tumor-specific cell surface proteomes, revealing
neomorphic gene products and non-canonical protein isoforms. In Aim 1, we will delineate tumor-specific
neomorphic and non-canonical cell-surface gene transcripts through the combined use of integrative long-read
and single-cell sequencing. Aim 2 will define the expression of neomorphic cell surface proteins directly using
integrative mass spectrometry proteogenomic approaches, focusing on non-canonical proteoforms and their
tumor-specific post-translational modifications. This approach includes rigorous technical validation measures
and aims to contribute to the NIH Cancer Data Science Initiative’s vision for an open data cancer ecosystem.
By addressing the critical gap in current cancer research methodologies and focusing on rare rhabdoid and
DSRCT tumors, this project stands to make a significant impact on the understanding and treatment of
ultra-rare cancers, paving the way for the development of targeted therapies and improving patient outcomes.

Public health relevance
Project Narrative Children and adults with rare cancers such as rhabdoid and desmoplastic small round cell tumors have dismal outcomes with current therapy. The planned research project is relevant to public health because the development of comprehensive proteogenomic methods and elucidation of tumor-specific cell surface proteomes will provide candidates for new targeted therapies. The proposed research is highly relevant to the NIH and FDA mission and the urgent unmet need of defining therapeutic targets for rare tumors, thereby overcoming fundamental barriers towards the development of improved treatments for human cancer.